Cost-effectiveness and efficacy of a combined intervention to facilitate motor recovery following stroke

Project Summary/Abstract
The goal of this project is to investigate, in parallel, the clinical efficacy and cost-effectiveness of combining
aerobic exercise with repetitive task practice (RTP) to improve upper extremity motor recovery in individuals
with stroke compared to time-matched RTP. Current approaches to stroke rehabilitation involve time-intensive,
therapist-directed task practice that, while efficacious, are not easily translatable into the clinical setting, in part
due to managed care reimbursement models that cap rehabilitation. The identification of a safe and cost-
effective approach, such as aerobic exercise, to facilitate neuroplasticity post-stroke would optimize motor
recovery while reducing costs associated with intensive rehabilitation. Our novel approach to stroke
rehabilitation exploits the physiologic effects of intensive aerobic exercise training and combines it with an
abbreviated session of motor task practice to improve motor recovery. This application of aerobic exercise
training paired with RTP has been shown in our preliminary study (NIH R03HD073566) to enhance motor
recovery greater than time-matched RTP without an aerobic exercise component. Results from our R03
indicated that those completing an 8-week high-rate aerobic exercise intervention paired with an abbreviated
session of RTP exhibited an 8-point or 26% improvement in Fugl-Meyer scores at end of treatment despite
completing 40% fewer RTP repetitions than the control group (time-matched RTP), that achieved a 17%
improvement in Fugl-Meyer scores. The combined approach is expected to be more cost-effective, given that
decreased one-on-one time is required, and clinical outcomes were superior in our preliminary study.
Improvements in cardiovascular fitness and lower extremity motor function were also evident in the aerobic
exercise group, indicating that the economic impact may extend beyond simply improving upper extremity
function, and has the potential to reduce disability and diminish indirect costs associated with stroke. Positive
results from our preliminary trial provide rationale for a systematic and larger scale trial to determine the clinical
efficacy and cost effectiveness of aerobic exercise in facilitating motor recovery following stroke. A total of 60
individuals with chronic stroke will be randomized into one of two groups: 1) aerobic exercise and RTP or 2)
time-matched RTP only. Both groups will receive an identical dose of contact time over 8 weeks (3X per week).
Clinical and biomechanical outcomes measuring change in upper extremity motor function and quality of life
metrics will be obtained, in addition to extensive participant demographics, and incorporated into decision
analytic models to determine the incremental cost-effectiveness of each intervention. These analyses will
examine cost-effectiveness in the short and long term from the healthcare provider and patient perspective,
and identify specific social determinants of health that impact the cost-effectiveness of the interventions.
Investigating and reporting the cost-effectiveness of each intervention represents a forward thinking approach,
as emphasis in medicine and rehabilitation progress toward models emphasizing value over volume.

Public health relevance
Project Narrative This project will investigate the efficacy and cost-effectiveness of a combined approach to stroke rehabilitation, in which aerobic exercise training is paired with upper extremity task practice, to improve motor recovery. We hypothesize that the aerobic exercise training may prime the brain, resulting in greater improvements in motor recovery at a reduced cost, compared to a time-matched task practice. Should this combined approach be found superior to traditional therapy as shown in our preliminary studies, and more cost-effective, it would serve to reduce the economic burden associated with stroke.